Cryo-electron tomography to determine crosstalk mechanisms of calcium channels in cardiomyocytes

PROJECT SUMMARY/ABSTRACT
Heart cells must precisely control the flow of calcium ions (Ca) within the cell to maintain a healthy heartbeat.
Contraction is initiated when L-type Ca channels (LTCCs) on the cell surface open and induce sarcoplasmic
reticulum (SR) Ca channels (RyR2) to release more Ca. This process is known as Ca-induced Ca release
(CICR). People with Ca handling dysfunctions develop arrhythmia and are at risk for sudden cardiac death and
heart failure. Yet, a detailed molecular and structural basis for CICR regulation in health and its dysregulation in
disease remains a mystery. The goal of this project is to use cutting-edge developments in cryo-electron
tomography (Cryo-ET), correlative light and electron microscopy, human induced pluripotent stem cell-derived
cardiomyocytes (hiPSC-CMs) and murine disease models, and CRISPR genome editing to determine the
structures and organization of CICR proteins in multiple clinically relevant states. In the mentored phase of this
award, the project will determine the localization of CICR proteins, the complexes they form, and their
conformational state, both at rest and during β-adrenergic receptor stimulation. In the independent phase of the
award, the project will use time-resolved imaging to capture short-lived but functionally important assemblies to
dissect CICR refractoriness. At both stages of the project, healthy cells will be compared to disease models. This
work will provide unprecedented insight into the molecular mechanisms that regulate CICR and how mutations
in CICR proteins lead to arrhythmia. By connecting structural and cardiovascular biology, this project will provide
a proof-of-concept for a new approach to study diverse cardiovascular processes and aid the development of
precise therapeutics. It will also give Dr. Woldeyes the training and expertise necessary to start an academic
career with a focus on using Cryo-ET for cardiovascular imaging.
With the training support of this award and guidance from her mentors, her advisory committee members, and
collaborators, Dr. Woldeyes will be well positioned to establish her independent research career. Dr. Woldeyes’
long-term goal is to dissect the mechanisms of cardiovascular disease at high spatial and temporal resolution.
She is jointly mentored by Dr. Wah Chiu, a leader in the field of cryo-electron microscopy/tomography and Dr.
Joseph Wu, a leader in the use of patient-derived iPSC-CMs to study cardiovascular diseases. Both have
excellent track records in mentoring and transitioning trainees to independent academic careers. Their labs are
an ideal environment for conducting the proposed experiments. With the resources and faculty available at the
Cardiovascular Institute, SLAC National Laboratory, Stanford, and the MOSAIC UE5 program, she will have the
training, support and intellectual input needed to ensure the success of this research project, enhance her career
development, and prepare her for the transition to a successful independent research career.

Public health relevance
PROJECT NARRATIVE Our hearts must precisely control the flow of calcium ions within each cell to maintain a healthy heartbeat. Many questions remain about the subcellular organization and function of the calcium channels that mediate the flow of calcium, and multiple cardiovascular diseases are associated with mutations in these channels. This research proposal will use a novel imaging approach to study calcium channels within heart cells at unprecedented detail and test multiple hypotheses about the structure and organization of calcium channels and their dysregulation in disease in order to aid the development of precise therapeutics.